THE CONTRACTOR WILL SUPPORT THE NIDA SUMMER RESEARCH INTERNSHIP PROGRAM BY PROVIDING LOGISTICAL SUPPORT TO MANAGE REIMBURSEMENT OF AUTHORIZED EXPENSES FOR INTERNS AND RESEARCH SITES, MANAGING THE TIME

Summer Research Internship Program Logistical Support